Compartmentalized cAMP signaling in reactive astrocytes

PROJECT SUMMARY
Glaucoma is the leading cause of irreversible blindness and along with other optic neuropathies is
characterized by the loss of retinal ganglion cells (RGCs). Increased intraocular pressure (IOP) management is
the current standard of care for glaucoma patients, but fails to stop the irreversible loss of RGCs and
progressive visual dysfunction. Glaucomatous RGC death was recently found to be driven by reactive optic
nerve head (ONH) astrocytes, suggesting targeting these (and other) glial populations in the retina may be a
viable strategy to protect RGCs. We recently discovered nuclear and cytoplasmic pools of cAMP, dependent
on expression of soluble adenylyl cyclase (sAC), and associated with the stress-induced cell cycle inhibitor
p21Cip, differentially regulate reactive astrocyte proliferation, microglial/macrophage activation, and RGC
survival after traumatic optic nerve injury. Here, using a newly developed and reversible model of glaucoma in
mice, we will establish the molecular, cellular, and transcriptional mechanisms that confer specificity to
neurotoxic and protective astrocyte reactivity regulated by compartmented cAMP, sAC, and p21Cip in ONH
astrocytes and Muller glia. An exciting element of our proposal is the use of state-of-the-art single cell RNA
sequencing and cut-and-tag assays to identify the transcriptional and (epi)genetic changes induced by
compartmented cAMP manipulation, and link those changes to reactive phenotypes in astrocytes and
downstream effects on RGC survival and microglial/macrophage infiltration. All of this will be accomplished
using novel AAV viral vectors to specifically target ONH astrocytes and Muller glia. These experiments will lead
to the discovery of new biological pathways that regulate glial reactivity in neurodegenerative disease, and
serve in the development of gliotheraputics for the treatment of glaucoma and other optic neuropathies.

Public health relevance
PROJECT NARRATIVE